Repeated Administration of Cannabis Varying in THC and CBD: Effects on Abuse Liability, Experimental Pain and Plasma Endocannabinoids

The majority of the >1.2 million registered medical cannabis patients in the U.S. cite pain relief as their primary
reason for using cannabis products. Although cannabis and its constituents (cannabinoids) have potential for
the treatment of chronic pain, there are critical gaps in our knowledge regarding the effects of repeated
cannabis administration on pain, abuse liability and circulating endogenous cannabinoid (eCBs) levels. The
endocannabinoid system plays a critical role in CNS function, yet the impact of cannabis use on circulating
eCBs is poorly understood. There is also little known about the effects of cannabis with varying concentrations
of oral D9-tetrahydrocannabinol (THC) and cannabidiol (CBD), the two most commonly used cannabinoids by
medical cannabis patients. This project is designed to answer three questions that will fill important voids in our
understanding of sustained cannabis use: 1) does tolerance develop to the analgesic and abuse-related effects
of repeatedly administered cannabis with varying ratios of THC and CBD, and is this tolerance reversible
following a period of abstinence; 2) is abrupt cessation of cannabis with varying ratios of THC and CBD
associated with withdrawal-induced hyperalgesia; 3) how does repeatedly administered cannabis with varying
ratios of THC and CBD modulate levels of circulating eCBs, and are these changes associated with altered
pain sensitivity and abuse liability? Prior to inpatient testing of cannabis administration, we will use contingency
management procedures to engender sustained abstinence in healthy cannabis users in order to minimize
existing tolerance. We will then enroll participants (N=100) inpatient for 15 days. They will be randomized to
one of four cannabis conditions (n=25/group): 1) high THC:low CBD, 2) low THC:low CBD, 3) high THC:high
CBD, 4) low THC:high CBD). Cannabis will be administered repeatedly for the first 7 inpatient days, followed
by a 7-day abstinence period. The last study day (day 15) will re-introduce the assigned active cannabis dose
to assess reversal of tolerance. At set time points within each condition, we will measure abuse-related effects
(“Good Drug Effect”), plasma eCB levels and two distinct types of experimental pain: The Cold Pressor Test
and Quantitative Sensory Testing Thermal Temporal Summation. Given the widespread use of cannabis for
pain, understanding the consequences of daily repeated administration of cannabis with THC:CBD ratios that
are representative of most medical cannabis products on pain, abuse liability, and eCBs is imperative.
Tolerance to the abuse-related but not analgesic effects would be salutary, but the converse could contribute
to the higher incidence of cannabis use disorder observed in medical cannabis patients. Similarly, if abrupt
cannabis cessation exacerbates pain, medical cannabis patients will have difficulty ceasing cannabis use.
Demonstrating a relationship between circulating eCBs and pain sensitivity can be used to help develop safe
and effective cannabinoid-based pain treatments. Overall, this proposal will provide significant public health
data for the large number of patients using a range of vaporized cannabis products for pain relief.

Public health relevance
Cannabis and its constituents (cannabinoids) have potential for the treatment of chronic pain, yet there are critical gaps in our knowledge, particularly regarding the effects of daily cannabis use. This proposal will assess the effects of repeated administration of vaporized cannabis with varying amounts of THC and CBD on: experimental pain, abuse liability and endocannabinoids, which play an essential role in brain function. The outcome of this study will provide significant public health information about the consequences of daily cannabis use for the large number of medical cannabis patients in the U.S.